Great Lakes NARCH 13 Admin Core

ABSTRACT: GLNARCH Administrative Core
This Great Lakes Native American Research Centers for Health (GLNARCH) application incorporates novel
approaches to build upon established partnerships that create a fertile environment for health research and
training. The proposed administrative core will be housed at the Great Lakes Inter-Tribal Council (GLITC) in
partnership with the Medical College of Wisconsin (MCW) and University of Wisconsin-Milwaukee (UWM).
GLNARCH objectives also require coordination across a broad geographic region which corresponds to the
overlapping GLITC/Bemidji services areas. This region is historically underfunded (see map in Overall
Component) relative to the southern Great Lakes in which larger academic institutions are based. The
following GLNARCH administrative core aims will enable the team to both expand and mature existing
partnerships. Each component of GLNARCH draws upon our established best practices which will benefit from
culturally responsive coordination. Specifically, GLNARCH administrative core provides integrating support for
the GLNARCH components guided by the overall theme of “learn something every day” (gikendan gegoo
endaso giizhig).